Novel Strategies for Treating Biofilm-Forming Pathogens with Phage Therapy

Project Summary
The growing antibiotic resistance problem requires that we urgently develop and test new approaches
to controlling bacterial infections. Phage therapy approaches offer great promise, but significant
knowledge gaps currently exist that limit their application. Two issues that currently limit the broader
use of phage therapy are the problem of curating specific lytic phage strains for each infection, and the
difficulty of delivering phages directly to the infection sites where they are needed. We hypothesize that
bacterial pathways that typically promote biofilm-associated growth can be decoupled from the stress-
response pathways capable of inducing resident prophages. By separating these cellular responses,
we propose to stabilize biofilms while also inducing temperate phages already present in the bacterial
genome to enter lytic phase and kill the host cell. In so doing, we effectively bypass the limitations
imposed by finding and delivering strain matched lytic phages to infections, while also developing
approaches that make use of temperate phage therapy approaches. In Aim 1, we propose to determine
biofilm dispersal rates and ascertain how biofilm-associated growth can be manipulated using cellular
pathways. In Aim 2, we will analyze mechanisms by which lysogens can be induced into lytic phase to
kill their hosts without spreading virulence factors beyond the biofilm. In Aim 3, we reinforce the
approaches of the previous aims with an optimized lytic phage ambush of any escaping dispersers.
The goals of this proposal are to develop an innovative, multi-pronged approach to phage therapy for
biofilm-associated bacteria while also increasing overall knowledge of the limits and applicability of
phage therapy.

Public health relevance
Project Narrative The aim of the proposed work is to assess the viability of a multi-pronged phage therapy approach to eliminate biofilm-associated bacteria. Specifically, we propose to induce prophages already contained within biofilm-associated bacteria to disrupt biofilms. Simultaneously, lytic phages will be applied to kill bacteria dispersing from the biofilm at the point of exit. This dual strategy may allow the eradication of intransigent infections resistant to traditional antibacterial therapy.